Recruitment and Phenotyping Core

Project Description: The broad objective of CORE B is to facilitate the successful completion of all projects by providing high quality cardiac phenotyping in animal (Doppler echocardiography and invasive hemodynamics) and human (Doppler echocardiography) studies. Further, we will assist in human subject identification for projects with human study components.